OpenNeuro: An open archive for analysis and sharing of BRAIN Initiative data

Project Summary/Abstract
The BRAIN Initiative is supporting a broad portfolio of neuroscience research aimed at revolutionizing our
understanding of the brain. The sharing of data obtained from this research is critical both to leveraging this
major public investment and to ensuring the rigor and reproducibility of NIH-funded research. We propose a
renewal of support for the OpenNeuro data archive, which provides a platform for the storage, processing, and
sharing of neuroimaging data collected as part of the BRAIN Initiative. OpenNeuro enables researchers to easily
share a broad range of neuroscience data types, based on the Brain Imaging Data Structure standard for
organizing datasets. The platform shares data openly and provides researchers with several avenues to access
and reuse the data. In the renewal period we propose to continue supporting a high level of performance for the
archive, and to extend the work done in the initial grant period. First, we will provide a specialized portal for
BRAIN Initiative investigators, which will help more clearly link their research to funding sources, and to provide
them with the ability to more flexibly select an appropriate data use agreement. We will also implement enhanced
user profiles, linking shared datasets to standard researcher identities through the ORCID system. Second, we
will enhance the ability to search for datasets by improving the ability for researchers to specify metadata that is
linked to standard ontologies. Third, will improve the reusability of OpenNeuro datasets by providing support for
the sharing of derivative data as well as statistical models, and by providing preprocessed data and quality
control reports. Together, these improvements will sustain the success of the OpenNeuro archive and provide
neuroscientists with increasingly usable data to address fundamental problems of brain function and health.

Public health relevance
Project Narrative We propose a renewal of support for the OpenNeuro data archive, which provides a platform for the storage, processing, and sharing of neuroimaging data collected as part of the BRAIN Initiative. OpenNeuro enables researchers to easily share a broad range of neuroscience data types, based on the Brain Imaging Data Structure standard for organizing datasets. Ongoing support for the platform as well as a set of improvements will sustain the success of the OpenNeuro archive and provide neuroscientists with increasingly usable data to address fundamental problems of brain function and health.